Validating the hybrid epithelial/mesenchymal state as a biomarker of treatment response and outcomes in head and neck cancer

PROJECT SUMMARY
Head and neck squamous cell carcinoma (HNSCC), including oral cavity squamous cell carcinoma (OCSCC) is
the sixth leading cause of cancer-related mortality, with the majority of deaths attributable to tumor metastasis
and failures in treatment. Because most cases of OCSCC result from tobacco and alcohol exposure, these
tumors are highly heterogeneous, greatly complicating diagnosis, treatment, and investigations into the biology
of this disease. We recently performed single cell RNA-sequencing (scRNA-seq) in OCSCC and identified a
hybrid epithelial/mesenchymal state (HEM) with some features of classical EMT, yet persistent expression of
epithelial markers (Puram et al., Cell). Further investigation into HEM demonstrated its localization at the leading
edge of tumors where it appears to drive invasion and metastasis. Accordingly, HEM is associated with adverse
pathology and poor prognosis, with a stronger effect on survival than even smoking. Strikingly, HEM appears to
be a strong predictor of outcomes in both Black and White Americans (Mazul et al., Med), suggesting it may be
useful in diverse sociodemographic groups. Based on these findings, we hypothesize that the HEM state is
regulated by the complex interplay between malignant, immune, and stromal cells, and will reliably predict
unfavorable outcomes in diverse OCSCC patients in treatment-naïve and recurrent/metastatic settings. First, we
will validate a RNA-seq based HEM heterogeneity score to predict outcomes in a diverse cohort of 400 treatment
naïve (including 150 Black American) OCSCC patients (Aim 1). However, we are also curious if HEM may predict
outcomes in the recurrent/metastatic setting (Aim 2). Because these patients typically have limited tissue
sampling due to tumor accessibility, bulk RNA-seq methods on fresh frozen tissue may be challenging. Thus,
we will first define the effect of HEM on immune infiltration using multiplexed, multispectral imaging (MSI)
approaches, followed by determining if MSI metrics of HEM predict outcomes in recurrent/metastatic patients. In
addition, preliminary MSI analyses reveal that HEM leads to exclusion of tumor infiltrating lymphocytes including
T-cells. Thus, we will also test whether HEM may predict immunotherapy response, which is front line therapy
in recurrent/metastatic OCSCC patients: We will utilize MSI to analyze patients tumors treated with immune
checkpoint inhibitors (ICI) to establish imaging-based metrics that predict response. If successful, our studies
will authenticate HEM as a critical biomarker in OCSCC to risk stratify biologically favorable and unfavorable
disease, improving patient expectations regarding disease outcomes, better informing patient-physician
interactions regarding treatment decisions, and enabling future clinical trials for high risk OCSCC tumors using
targeted therapy or potentially intensifying adjuvant therapy beyond standard-of-care treatment. Because no
molecular markers of OCSCC are routinely used in clinical practice, these efforts represent an urgent and unmet
need, which if addressed could significantly impact the management of these challenging patients and create
opportunities for more personalized treatment through future studies.

Public health relevance
PROJECT NARRATIVE Although progress has been made in oral cavity squamous cell carcinoma (OCSCC), the mainstays of treatment continue to be surgery, radiation, and chemotherapy, with no reliable method for prognostic stratification of patients. This study will mature the use of a hybrid epithelial/mesenchymal (HEM) program as a biomarker in OCSCC using genomic and image-based classifiers. Our overarching goal is to determine if an HEM-focused biomarker may predict patient outcomes in treatment naïve and recurrent/metastatic OCSCC, including response to treatments such as immunotherapy, to enable improved patient decision-making and develop more personalized clinical management that matches biologic risk with treatment interventions.